Propriospinal Plasticity and Recovery After Incomplete Spinal Cord Injury.

Project Summary/Abstract: After a spinal cord injury (SCI) some neurons undergo anatomical expansion of
their terminal fields via collateral sprouting that may be adaptive, leading to improved recovery, and/or
maladaptive, leading to reduced recovery. However, as a field we have had few opportunities to directly link
observed anatomical plasticity of spinal cord interneurons with functional changes. We have used virus-based
tools to synaptically silence or anatomically trace specific spinal cord interneurons, the long-ascending
propriospinal neurons (the LAPNs) that reside at L2 and project to C6, segments critical for hindlimb and
forelimb activity during locomotion. Our recent work suggests that LAPN plasticity after a SCI may be
maladaptive and impede or limit functional recovery. In combination with iDISCO tissue clearing and confocal
imaging we are studying their dendritic and axonal anatomy before and after a variety of SCIs in the adult rat.
In addition, our main collaborator on this project will enable us to use tried and true anterograde tract tracing to
characterize interactions between reticulospinal axons and the LAPNs, before and after a contusive spinal cord
injury and following a standard lateral hemisection injury. For both video and machine-learning aided locomotor
analysis and as a novel activity/training strategy we use a 10 foot long plexiglass tank that allows the animals
to run back and forth expressing the full range of speed-dependent gaits and gait transitions. With these tools
we will investigate the anatomical plasticity exhibited by LAPNs after a T9 contusion injury in male and female
SD rats, and in females only with and without acute or chronic activity/training (Aim 1), the impact of silencing
the LAPNs on both acute functional recovery and chronic recovered function after a T9 injury (Aim 2) and the
roles the LAPNs play in recovered function following a lateral hemisection where the silenced LAPNs are either
spared or axotomized (Aim 3). These studies will have translational importance for cell and drug therapies in
addition to neuromodulation approaches including epidural and transcutaneous spinal cord stimulation and will
allow us to address the confusing adaptive/maladaptive concepts driving the neuroanatomical-functional
paradox that plagues the field of spinal cord injury.

Public health relevance
Project Narrative. This project focuses on the role that plasticity of the long ascending propriospinal neurons (LAPNs) plays in the recovery of locomotion after a spinal cord injury. We will use a combination of contusion and hemisection injuries, viral-based synaptic silencing and tracing, tissue clearing, IHC with confocal imaging, and comprehensive gait and kinematic analysis to gain a deeper understanding of how adaptive (good) and maladaptive (bad) plasticity of interneurons promotes or prevents recovery and if acute or chronic activity/training can influence the process.